Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
B. Mark Evers, MD, (TO) Director of the Markey Cancer Center (MCC), is assisted by eight Senior Leaders
who support activities in cancer research, outreach, education and training, diversity and inclusion, clinical care
and administration. With the exception of some notable additions during this reporting period that have
expanded the effectiveness and expertise of the Senior Leadership team, this highly experienced group of
leaders has worked together since 2009, overseeing MCC’s initial NCI designation in 2013, a successful
renewal application in 2018, the preparations for this renewal and quest for Comprehensive Cancer Center
status, as well as a future five-year outlook in the form of MCC’s FY24-28 Strategic Plan. MCC’s Senior
Leaders leverage all available resources at the University of Kentucky, state and national levels to further their
cohesive plan to fulfill MCC’s mission to reduce the cancer burden with a focus on Kentucky and its most
vulnerable populations through research, prevention, treatment, education and community engagement. To
that end, MCC’s Leadership, Planning and Evaluation efforts are centered around the following Specific Aims:
1) Implement and execute MCC’s FY24-28 Strategic Plan and lead MCC based on the opportunities and
needs of the statewide catchment area and in tandem with institutional and NCI priorities; 2) Lead the ongoing
planning and evaluation of the center, coordinating and responding to internal and external reviews; and 3)
Ensure the appropriate resources and infrastructure to foster success across all areas of MCC’s Strategic
Plan, including the success of MCC’s Research Programs, Shared Resources, clinical and translational
scientific endeavors, and outreach, mentoring, and diversity-focused initiatives. MCC’s planning and evaluation
efforts, sustaining its substantial growth since 2018, are accomplished through External and Internal Advisory
Boards that meet regularly, the Director’s Council and committees that provide both the Director and Senior
Leadership ongoing guidance and support. Future directions for the center are guided by plans outlined in
MCC’s FY24-28 Strategic Plan, which was constructed through an extensive review and vetting process with
input from key internal and external stakeholders. The plan is a living document and roadmap to guide the next
five years of excellence in key pillars of activity across the center: 1) basic research, 2) clinical translation, 3)
cancer prevention and control, 4) cancer education and mentoring, 5) community outreach and engagement,
6) diversity, equity and inclusion, and 7) clinical care. These pillars are reinforced by strong institutional
support, philanthropy, Shared Resource Facilities, and administration, all of which work in tandem to support a
cancer center poised to continue its trajectory of increasing contributions to cancer research, training,
education, equity and outreach.

Public health relevance
Project Narrative Not applicable. This document is attached to satisfy electronic submission requirements.